Dissecting a novel prefrontal cortical pathway regulating feeding behavior

PROJECT SUMMARY/ABSTRACT
Eating disorders, spanning obesity to anorexia, are highly prevalent and problematic in our society. They are
difficult to treat, affect a large proportion of the population, and underlie many other causes of morbidity that
have become increasingly costly to manage. Furthermore, feeding behavior is upset in multiple psychiatric
disorders and weight gain is a common side effect of many psychotropic medications, but the pathophysiology
of these effects is unknown. Therefore, the study of feeding behavior and the neurocircuitry of metabolism are
of great interest to psychiatry.
Using cutting-edge neuroscience tools to build on traditional genetic methods, the applicant proposes a
functional mechanism for projections from satiety-associated neurons in the hypothalamus (POMC neurons) to
medial prefrontal cortex melanocortin-4 receptor-expressing neurons (mPFCMC4R) in the pathophysiology of
overeating related to obesity. In this mouse-based study, the applicant will examine a novel pathway from
POMC neurons to the infralimbic region of the mPFC and investigate the relevance to feeding behavior. First,
she will determine if mPFCMC4R neurons, and specifically those that receive projections from POMC neurons,
play a role in executive function specific to food-related decisions, focusing on set-shifting and rule reversal
(Aim 1). Next, she will perform the same behavioral assays while recording the activity of the mPFCMC4R
neurons in awake, behaving mice (Aim 2). These studies will employ genetically engineered mice and viruses
that together enable temporal and spatial control and study of specific subpopulations of neurons, and will be
performed in both male and female mice. Together, these aims will show that the POMCà mPFCMC4R circuit is
a key node in the development of overeating behavior, and consider sex-specific vulnerability to overeating at
this unique site of integration of feeding behavior and executive function. Further, this work will provide new
animal models for future research with dissociable behavior and physiologic outputs as well as potential
therapeutic targets which are urgently needed for eating disorders.
The applicant, Dr. Rachel Ross, is well qualified to execute the proposed experiments. She is committed to
pursuing a scientific career in neuroscience of behavior and has proposed a comprehensive four-year plan to
meet her goal of becoming an independent physician-scientist. Dr. Ross will be working under the primary
mentorship of Dr. Kerry Ressler with co-mentorship from Dr. Bradford Lowell. She has enlisted a research
advisory committee of internationally-recognized experts in neuroscience and psychiatry to support her. The
Department of Psychiatry at McLean Hospital (and secondary site of the Division of Endocrinology at Beth
Israel Deaconess Medical Center) is an ideal environment for completion of her scientific and career
development objectives given the outstanding research community, tradition of scientific discovery, and
ongoing dedication to trainee mentorship in this field.

Public health relevance
PROJECT NARRATIVE Overeating is a significant cause of obesity, but it is unclear what drives the behavior. Human imaging studies investigating obesity indicate a role for the prefrontal cortex, a region of the brain involved in executive functions, like decision making and learning associations. In this study, I will probe subpopulations of cells and neural circuits in the medial prefrontal cortex using novel mouse models and cutting-edge neuroscience techniques to directly study decision making related to food which will provide novel cell-type and specific circuit-based targets to lay the groundwork for pharmacologic and non-invasive interventions to treat obesity and its associated conditions.